Admin Core

Project Summary/Abstract – Admin Core
This program project grant includes three Projects and four Cores, inclusive of this Administrative Core. We
propose a highly collaborative scientific research program with clear and deep synergies between the basic
science discovery, in vitro and in vivo pre-clinical modeling and a clinical trial. This collaborative program includes
key investigators from the Divisions of Transplantation and Cellular Therapies, the Pediatric Transplantation
Program, and the Department of Biostatistics at Dana Farber Cancer Institute, as well as investigators at
Children’s Hospital Boston and the University of Minnesota. Several other centers are represented as
contributors to individual Projects. To accomplish these goals, a centralized Administrative Core is proposed.
This core will coordinate the efforts of all the investigators and collaborators involved in this Program; organize
and conduct meetings of P01 participants and annual meetings of Program Project participants; prepare the
necessary documents related to Program Project activities, including reports of Program Project investigator
meetings, and prepare progress reports for official agencies; facilitate interaction between individual Projects
and between Projects and Cores and monitor the progress of the individual Projects on a regular basis; maintain
appropriate fiscal oversight of the Projects and Cores and prepare necessary fiscal reports of official agencies;
and assure compliance with appropriate regulations regarding experimentation with human subjects and
vertebrate animals. Coordinating all of these administrative facets will be a key to the success of this Program.